MOLECULAR STUDIES OF PROTEIN-DNA INTERACTIONS

We seek to understand at a molecular level the various ways by which an organism maintains the integrity of its genome while accommodating the need for diversity. Our research efforts currently focus on two related processes, homologous recombination and DNA mismatch repair. We are characterizing a central step in genetic recombination, DNA branch migration. DNA branch migration involves the step-wise breakage and reformation of hydrogen bonds in Watson-Crick base pairs as one DNA strand is exchanged for another. Branch migration dictates the amount of genetic information transferred from one chromosome to another. Using branch migration substrates that contain a positioned nucleosome core, we have determined that a histone octamer is a barrier to spontaneous branch migration. Our studies of the kinetics of DNA branch migration indicate that in eukaryotes, proteins are required not only to facilitate rapid, unidirectional branch migration, but also to facilitate passage of the Holliday junction through nucleosomes. Mismatch repair, exemplified by the E. coli methyl-directed mismatch repair pathway, plays critical roles in maintaining the integrity of a genome. Mismatches can arise through DNA replication errors, homologous recombination and spontaneous DNA damage. Components of the bacterial mismatch repair system encoded by the mutS and mutL genes in E. coli, are highly conserved in both prokayotes and eukaryotes with defects in human genes encoding mismatch repair enzymes being implicated in hereditary colon cancer. We are interested in understanding the molecular mechanism involved in mismatch recognition by the MutS protein. Biochemical studies of a thermostable MutS protein from Thermus aquaticus reveal that MutS protein contacts the major and minor grooves in the vicinity of a mismatch or unpaired base. In addition, photocross-linking and site-directed mutagenesis have identified a region of MutS protein involved in heteroduplex DNA binding.